New Mexico MFRPS Implementation

Project Summary/Abstract
Given the large impact of New Mexico’s food manufacturing industry, providing high quality,
consistent inspections based on the scientific principles of food safety is paramount to protecting
New Mexicans and consumers throughout the nation and world. Furthermore, the ability to
identify and respond quickly to public health events impacting New Mexico through a well-
planned and coordinated Rapid Response Team (RRT) is paramount to preventing the spread
and/or continuation of public health related events.
In addition to Several large food processors have operations in New Mexico (NM) including:
General Mills, Kraft, Coca Cola, Santa Fe Tortilla Company, Bueno Foods, Border Foods, and
Albuquerque Tortilla Company, the New Mexico Environment Department (NMED-EHB) has
experienced a substantial surge in the number of small local producers seeking to begin food
manufacturing. In 2015 NMED-EHB identified an inability to keep up with the growing number
of questions and requests to provide assistance and speak to various groups or to develop a
program conforming with the MFRPS. Since obtaining “MFRPS cooperative agreement” in
2015, NMED-EHB has made significant progress in conforming with the MFRPS by achieving
conformance with five standards and through the expansion of staffing, has been able to begin
providing assistance to new and existing food manufacturers throughout the state.
In addition to having adequate resources and time to respond to questions, applications, plan
reviews, operational plans, recalls, training requests, and fulfilling staff training requirements,
NMED-EHB now also able to provide scientifically, risk-based inspections with a small team of
properly trained and audited inspection staff. Raising the level of staffing and education/training
of this team has proven immediately beneficial to NM-produced manufacturing as the team has
discovered significant issues previously undiscovered by other staff conducting manufactured
food inspections. Corrections are being handled in a timely manner in accordance with SOPs.
NMED-EHB anticipates participation in the Flexible Funding Model Cooperative Agreement
will result in further increasing the effectiveness of protecting public health nationwide and will
result in full conformance with the MFRPS by the completion of Y1 of this agreement. After
conformance is achieved in Y1, NMED-EHB anticipates maintaining conformance with the
MFRPS through established monitoring practices and will strive to continually improve through
envisioned continuous improvement initiatives. This will be accomplished by the following:
• The State will achieve, monitor, and successfully sustain full conformance with
the Manufactured Food Regulatory Program Standards (MFRPS) by completion
of Y1;
• The State will actively engage through an annual face-to-face meeting and
participation in committees supporting MFRPS;
• The State has and will collaboratively develop strategies and share those
strategies with other states;
• The State will provide FDA the foundation for pursuing regulatory action based
upon the findings of State manufactured food regulatory programs; and
• The State will seek to further enhance its capability to protect public health
through development and implementation of Standard Enhancement Projects and
continuous improvement initiatives.
The goal of this project is to build a manufactured food program to protect consumers throughout
the state and beyond. At minimum, absent major unforeseen difficulties, significant conformance
will be attained with the Manufactured Food Regulatory Program Standards.

Public health relevance
Project Narrative NMED-EHB’s focus is to implement the Manufactured Food Regulatory Program Standards (MFRPS) by conducting program self-assessment, operating from an effective strategic plan, developing policies and procedures, strengthening collaborations, to reach full conformance with the MFRPS and to maintain conformance with achieved standards and continually improve through effective and consistent monitoring practices. NMED-EHB will reach full conformance with the MFRPS in Y1 by completing the requirements outlined in Standard 10. This will be accomplished by signing a contract with an ANSI-Accredited laboratory and having a written agreement with the lab as its Primary Servicing Laboratory.